Development of neural processing of sound in infancy

7. PROJECT SUMMARY/ABSTRACT Human auditory development is characterized by a puzzling structural-functional paradox: infants show sophisticated auditory capabilities from the time they are born despite significant immaturities that exist in their central auditory system. These early auditory skills play a critical role in infants' ability to acquire language, appreciate music, and navigate the complex acoustic environments around them. The neural mechanisms that support early sound processing, however, are not well understood. In the mentored K99 phase of this award, the candidate will employ magnetoencephalography (MEG) to obtain functional measures of auditory processing in infants at different stages of anatomical maturation. The candidate will first test the prevailing hypothesis that early auditory perception is supported predominantly by subcortical processing with a transition to cortical mechanisms after six months of age (AIM 1). MEG responses will be recorded in infants to speech sounds and a complex non-speech control stimulus. The sources of the MEG signals will then be localized with the equivalent current dipole model. Clinical assays of development will also be administered to capture cross- domain functional changes that occur with changes in the neural processing of sound. Next, the candidate will characterize the development of functional specialization of speech processing using the late-field MEG responses recorded in the previous conditions (AIM 2). While left hemisphere dominance for speech has been well documented in adult listeners, how this functional asymmetry develops is unclear. Finally, in the independent R00 phase, infants with a mild-to-moderate hearing impairment will be tested to investigate the impact of abnormal auditory experience on central auditory maturation (AIM 3). This research will advance our understanding of the neural mechanisms underlying early sound processing and the role of auditory experience in their development. These findings will also contribute to our understanding of the mature neural networks involved in auditory processing and give context to investigations conducted in older children and adults. From a clinical perspective, this research has the potential to show that early identification and treatment of hearing loss is important for auditory brain development and could serve as the evidence-base for clinical recommendations. In the mentored phase of the award, the candidate will obtain training in hearing loss and MEG methods with a focus on source localization and movement compensation techniques. The University of Washington offers a unique team of mentors and consultants with expertise in auditory cortical networks, MEG analysis, neurodevelopment, and hearing loss to contribute the critical components of training. The research performed and training provided during this award will enable the candidate to achieve her goal of developing an independent research program that employs both neurophysiological and behavioral approaches to investigate typical and atypical auditory development.

Public health relevance
8. PROJECT NARRATIVE Infants' sophisticated auditory abilities allow them to learn speech, enjoy music, and navigate the noisy worlds around them but how the immature infant brain supports sound processing is unclear. This project uses magnetoencephalography to obtain functional measures of auditory processing in normal-hearing infants and infants with hearing loss. This research will advance our understanding of the neural mechanisms underlying early sound processing and has the potential to show that early identification and treatment of hearing loss is important for auditory brain development.